Non-Coding RNA and CKD Progression

Project Summary
Kidney fibrosis is the final common pathway downstream of most renal injuries that contributes to progressive
chronic kidney disease (CKD). Non-coding RNAs regulate kidney fibrosis through direct repression and/or
expression of matrix genes and through TGF-β signaling. Our central working hypothesis is that specific
circulating and urinary microRNA and long non-coding RNA (EncRNA) are indicators of underlying kidney fibrosis
and hence are early biomarkers for CKD progression. We will use the Chronic Renal Insufficiency Cohort Study
(CRIC) biosamples and associated data. The study will be conducted in three phases; discovery, replication
and an experimental validation phases. Next-generation sequencing will be used to profile the ncRNAs in blood
and urine samples from participants exhibiting slow (n=191) and fast (n=192) progression of CKD. Top CKD
progression-related ncRNA discoveries will be replicated in 3,088 CRIC study participants using quantitative RT-
PCR. The primary renal phenotypes of interest are the slope of change in estimated glomerular filtration rate
(eGFR), and either time to end-stage kidney disease (ESRD), or a composite of time to ESRD or a 50% reduction
in eGFR. We will employ innovative in vitro experiments and in vivo gain and loss of function experiments in
mouse models to identify targets and validate the functional significance of the EncRNA discoveries from human
studies. Finally, we will verify the expression level of the top EncRNA discoveries in the microdissected CKD
kidney tissues. Identification of specific ncRNA pathways for the progression of CKD will enhance diagnosis,
enable risk stratification and lead to hypothesis driven targeted interventions.

Public health relevance
Project Narrative Progressive chronic kidney disease often results in widespread tissue scarring. Non-coding RNAs (ncRNAs) regulate the process of fibrosis. This study will examine whether specific plasma and urinary ncRNA profiles are associated with rapid loss of kidney function.